CONFERENCE--VIRUS ATTACHMENT AND ENTRY INTO CELLS

In the past several years, there have been many new developments in technology applied to the study of early events of virus infection. The purpose of this Conference is to provide a timely forum for the exchange of information and ideas pertaining to the diverse strategies of virus entry into cells. Attachment, penetration and uncoating of genomes of enveloped and non-enveloped animal viruses will be presented and discussed. Topics of major interest to be considered include: a) the nature of the receptors for attaching viruses and progress made toward the purification of receptors; b) virion attachment proteins that react with receptors on the cell plasma membrance; c) post-attachment events, i.e., fusion and virion modification leading to penetration; d) endosomes, receptosomes and lysosomes in viral genome uncoating; e) correlations between the specificity of attachment, penetration and uncoating and patterns of pathogenesis; f) inhibitors of virus entry into cells and their application in animal models; g) use of anti-idiotype antibodies as probes for receptor distribution; h) selection of virus variants (host range) by variant receptors; and i) role of receptors in a cellular function. An extraordinary group of speakers has agreed to participate at the Conference and full attendance by an audience of working scientists and graduate students is anticipated.